Leaders of Scientific Research Programs

The Program Leaders of the USC Norris Comprehensive Cancer Center (NCCC) promote both intra and inter-programmatic transdisciplinary research through careful selection of program members and recruitment of new faculty, coordination of interactions between program members and with other NCCC members, as well as facilitation and leadership of transdisciplinary and multi-project research applications, seminars, mini-symposia, program retreats and program meetings. This transdisciplinary emphasis is reinforced by having two leaders from different disciplines for most programs. For those programs with two leaders (Epigenetics and Regulation, Tumor Microenvironment, Cancer Epidemiology, Cancer Control Research, Developmental Therapeutics, Genitourinary Cancers, Gastrointestinal Cancers, Leukemia and Lymphoma and Women's Cancers) we are requesting support for 7.5% effort for each leader and for one program (Molecular Genetics) with one leader we are asking support for 10% effort.

Public health relevance
The Program Leaders facilitate scientific discoveries and coordinate activities to foster transdisciplinary research for the development of more effective prevention, diagnosis and treatment of cancer.